Patient Navigators for Children's Community Mental Health Services in High Poverty Urban Communities

Project Summary
The purpose of this grant is to study a model of mental health navigation for African American
and Latinx children in high poverty urban communities focused on reducing key parental
attitudinal barriers to care. Reducing persistent racial and ethnic disparities in children’s mental
health is a national priority and patient navigation is a highly promising approach that is rarely
used in children’s mental health services. The study will examine the effectiveness of two types
of navigators: paraprofessionals (PP) who have strong community knowledge, and case
managers (CM) who are formally trained. The study will examine specific mechanisms of
navigator effectiveness in children’s mental health and compare the two types of navigators to
provide a rigorous test of the proposed mechanisms. The knowledge gained from this
application may be important to reducing disparities and employing the workforce best suited to
navigation in the community mental health system. Two community boards, one focused on
identifying factors important to supporting navigators at the agencies, and the other focused on
implications for state and federal policy, will meet annually with the goal of identifying key
findings with the potential to influence local, state, and national priorities for children’s mental
health.

Public health relevance
Project Narrative The purpose of this grant is to study a model of mental health navigation for African American and Latinx children in high poverty urban communities focused on reducing key parental attitudinal barriers to care. The study will examine the effectiveness of two types of navigators: paraprofessionals who have strong community knowledge, and case managers who are trained to access formal community services. Two community boards, one focused on promoting inter-agency communication and support to enhance navigators’ effectiveness, and the other focused on implications for state and federal policy, will meet annually with the goal of identifying key findings with the potential to influence local, state, and national priorities for children’s mental health.